Genomics in Action

PROJECT SUMMARY/ABSTRACT
The goal of this project is to provide training and education in human genomics-related topics to the entry-level
biomedical workforce, and in particular, to individuals from underrepresented and disadvantaged populations.
Entry-level training in human genomics is critical for creating diverse teams of individuals who can be active
participants in genomic medicine. In response to this ongoing need, The Jackson Laboratory (JAX), in
partnership with Connecticut State Colleges and Universities (CSCU), proposes a curriculum development
initiative, Genomics in Action, for community college students that will impart content knowledge and skills in
genetics and genomics to better prepare them for a variety of careers, such as laboratory, medical and nursing
assistants. Community college students within the CSCU system are a highly diverse group, with approximately
50% of students receiving financial assistance and 50% of students from minoritized populations. To achieve
our objective, we propose the following Aims: 1. Develop 15 virtual modules on key topics in human
genomics, tailored to community college student needs. These modules will address curricular gaps as
identified through needs analysis with our CSCU faculty. Our innovative approach will utilize short video content
to introduce topics, demonstrate concepts, as well as provide context for each topic within a career or job in the
genomics workforce. Each module will feature a near-peer who is employed in a role for which community college
students are training. The modules will thus be designed to connect the genomics content and skills directly to
application in the workplace. 2. Disseminate fully digital modules to the broader community. Our team will
design modules that can be seamlessly integrated into our CSCU partner institutions learning management
systems, and professional development workshops will be provided to facilitate adoption the Genomics in Action
modules among the broader CSCU community. We will also expand dissemination through JAX’s online and
digital education program that provides free access to our interactive multimedia educational content, making
the modules available for use globally. To evaluate the impact of the Genomics in Action modules, pilot adoption
will take place during year 1 of the project and surveys will be administered to assess the effectiveness of the
module delivery and usability by both faculty and students. Modules will be adapted, refined, and subsequently
delivered in courses again in years 2 and 3. We will examine overall uptake and use of the modules by our
partner institutions and will track broader dissemination within other programs and institutions within the CSCU.
Program impact will also be assessed by tracking learners’ career progress and retention in biomedicine
following program participation. By training community college students seeking entry-level positions, Genomics
in Action will execute on NIH’s goal of strengthening the future STEM workforce through increasing genomic and
health literacy.

Public health relevance
PROJECT NARRATIVE The Jackson Laboratory, in partnership with community college faculty across the state of Connecticut, proposes to develop a curriculum program to improve genetics and genomics literacy among community college students preparing to enter the biomedical research workforce. By targeting students training for entry-level professions and by developing online content modules, we seek to train a broad and diverse audience. Our content modules will expand students’ understanding of how human genomics intersects with healthcare, ultimately strengthening the future STEM workforce.